Mechanisms of voltage regulation of membrane transport

Mechanisms of voltage regulation of membrane transport
SLC9 family of membrane transporters couple the import of sodium ions to export of protons.
They are vital for regulation of cytoplasmic and endosomal pH, which in turn affect several
physiological processes. Their disfunction has been linked to many diseases such as diabetes,
hypertension, heart failure and cancer. Genetic mutations in specific SLC9 members have also
been associated with Angelman-syndrome like disorders, ADHD, familial autism, epilepsies and
male infertility. The SLC9C1 is a unique member of the SLC9 family. Unlike other SLC9s which
feature a membrane delimited sodium-hydrogen exchange (NHE) domain and a usually short and
relatively unstructured C-terminal soluble domain, SLC9C1 combines an NHE, a voltage-sensing
domain (VSD) and a cyclic nucleotide binding domain (CNBD), interconnected via long, structured
linkers, in a single polypeptide. Recent foundational experiments have revealed that membrane
hyperpolarization and binding of cyclic nucleotides potentiates ion transport via SLC9C1. Its
unique design makes it impossible to predict how voltage and ligand regulation of this protein is
manifested at a structural level. SLC9C1 exhibits sperm-specific expression and has been shown
to be critical for sperm motility in mouse and humans. Sperm motility is robustly modulated by
changes in membrane voltage, intracellular cAMP levels and pH and all these stimuli influence
SLC9C1 mediated ion exchange directly, making it vital to understand the molecular
underpinnings of such diverse regulation. To this end, in this proposal we will integrate single-
particle cryo-electron microscopy and reconstruction techniques with biochemical and
electrophysiological methods to explore key biophysical mechanisms of SLC9C1. In Aim 1, we
will determine the first high-resolution structure of SLC9C1 and identify the key interactions
governing its organization. In Aim 2, we will elucidate the structural rearrangements in SLC9C1
triggered by cyclic nucleotide binding and use electrophysiology to test the role of a key interface
in mediating the regulatory effects of the CNBD. In Aim 3, we will determine how pH and permeant
ions affect the structure and function of SLC9C1. The proposal has a strong scientific foundation
built on our rigorous preliminary studies. It is innovative as it will provide the first snapshots of a
novel membrane protein in different conformations and test provocative hypotheses on the
mechanisms of voltage and cyclic nucleotide regulation of a transporter. The insights obtained
from our studies will aid structure-based drug design for treatment of male infertility. It will also
have broad implications on the structural and functional mechanisms of SLC9 regulation by their
cytoplasmic domains further underscoring its importance for human health.

Public health relevance
Project Narrative SLC9 family of membrane transporters play key roles in pH and salt homeostasis in all living cells and genetic mutations in these proteins have been linked to a variety of pathological conditions such as epilepsies, autism, digestive disorders, male infertility, etc. In this proposal we will determine high resolution structures and investigate functional mechanisms of a unique SLC9 family member, SLC9C1. This will advance our understanding of how this protein is regulated by physical and chemical stimuli and guide developments of new intervention strategies to treat pathophysiological conditions arising from disfunction of these proteins.